Molecular and structural mechanisms of metazoan origin licensing

Abstract
The survival of living organisms depends on the timely and accurate duplication of chromosomal DNA. Defects
in DNA replication jeopardize genome integrity and organismal viability and are linked to numerous diseases
ranging from developmental syndromes to cancer. Research in my laboratory is broadly focused on elucidating
the mechanisms that control the onset of DNA replication. In eukaryotes, DNA replication begins with the
binding of initiator proteins, the origin recognition complex (ORC), to DNA at replication origins. ORC
subsequently recruits and deposits the Mcm2-7 helicase motor onto DNA as an MCM double hexamer to
‘license’ these origins for DNA replication. Much of our knowledge about origin licensing and DNA replication
initiation is derived from studies using budding yeast as a model system, but how these steps are
accomplished in metazoan systems remains ill-defined mechanistically.
In the past, we have employed biochemical, biophysical, and structural approaches to uncover new,
fundamental principles for how eukaryotic ORC operates to license replication origins. For example, we have
determined high-resolution structures of ORC-containing assemblies in various functional states to define how
ORC binds DNA and cofactors, and how these activities are regulated. More recently, we have reconstituted
human origin licensing in vitro, which revealed that human Mcm2-7 can be loaded onto DNA through multiple
pathways, suggesting that not all human origins may be licensed through the same mechanism.
Despite these advancements, numerous questions persist with respect to the mechanisms that regulate origin
recognition and origin licensing in multicellular eukaryotes, which will provide the basis for our research
program in the next 5 years. Building on our strengths in biochemical reconstitution and in structural biology,
we plan to resolve how metazoan MCM loading intermediates mature into MCM double hexamers through the
various licensing pathways, how these pathways have evolved across multicellular eukaryotes, and how origin
licensing occurs in different types of chromatin contexts. In the long-term, our studies will help explain disease
mechanisms and aid in the development of new treatment modalities for diseases linked to dysregulated DNA
replication initiation such as cancer.

Public health relevance
Project Narrative The correct and efficient duplication of genetic information encoded in DNA is essential for cell proliferation, while dysregulation of this process is linked to human diseases such as cancer. Our research seeks to define the mechanisms that control DNA replication onset in multicellular organisms at a molecular and structural level. The knowledge gained from this work will be important for advancing our understanding of disease mechanisms related to DNA replication and for developing novel therapeutic strategies.